Profiling Translation in Nociceptor Plasticity

PROJECT SUMMARY/ABSTRACT
Chronic pain is pervasive and devastating. It diminishes quality of life for 20% of adults. An integral feature of
persistent pain is increased excitability in nociceptive sensory neurons. The molecular mechanisms that
orchestrate plasticity in nociceptors are unclear.
The integrated stress response (ISR) is a master regulator of neuronal function. Activation of the ISR triggers
global suppression of translation and initiates pain through direct effects on sensory neurons. Four upstream
kinases trigger the ISR through phosphorylation of the regulatory subunit of eukaryotic initiation factor 2. We
recently discovered that one of these kinases, general control nonderepressible 2 (GCN2) is uniquely critical.
Virtually nothing is known about the function of GCN2 in pain signaling. We will focus on resolving this problem
in the following two aims:
Aim 1 – Define the role of GCN2 in pain.
Aim 2 – Examine the landscape of translation in the DRG during neuropathic pain.
This work is broadly significant for the following reasons. The targets of translational regulation in neuropathic
pain are unclear. We apply a transformative genomics tool that reveals molecular underpinnings of translational
regulation with astonishing molecular clarity. Parallel experiments will identify relevant factors using a novel
CRISPR/Cas9 in vivo perturbation strategy. The master regulatory factors that govern translational regulation in
neuropathic pain are unclear. Our preliminary data at the molecular, cellular, and organismal levels provide
strong evidence that GCN2 is critical.

Public health relevance
PROJECT NARRATIVE Poorly managed pain creates an enormous burden on our healthcare system and produces tremendous human suffering. This project examines fundamental processes that underlie chronic pain. We apply an array of functional genomics approaches to address the role of post-transcriptional gene controls in nociceptive sensory neurons.